Dissecting functional roles of MeCP2 condensates in neurons with chemogenetic tools

Project Summary
Nuclear condensate formation by chromatin regulatory proteins and transcription factors is a new paradigm for
explaining genome partitioning and gene regulation mechanisms. Recent studies showed that disease-
associated mutations of DNA-binding protein, such as MeCP2, are associated with aberrant condensate
formation and disrupting the heterochromatin domains. However, the most current studies of phase-separation
by nuclear proteins are limited to in vitro biochemical studies and overexpression studies in cells showing the
formation of puncta or nuclear bodies, which are insufficient to dissect the molecular function of endogenous
protein condensates in disease. To address these issues, the objective of this R21 application is to develop
novel chemogenetic tools for manipulating, monitoring, and testing endogenous MeCP2 condensates in neurons.
Specifically, we will develop SPARK-OFF to dissolve MeCP2 condensates and SPARK-ON to restore
condensation for MeCP2 mutants from Rett Syndrome patients in differentiated neurons. Through sequencing
analysis, we will further investigate the roles of MeCP2 condensates in chromatin regulation, chromatin structure,
and gene regulation. Our study will provide new technologies for studying the biological function of nuclear
condensates in the nervous system and help demystify the causal relationship between MeCP2 condensates
and Rett Syndrome etiology.

Public health relevance
PROJECT NARRATIVE Perturbation of certain condensate formation is associated with diseases. However, the functions of condensates remain elusive due to the lack of tools to manipulate and monitor condensate formation by endogenous proteins. In this proposal, we plan to develop novel chemogenetic tools to manipulate, monitor, and investigate MeCP2 condensates in regulating chromatin structure and gene expression in neurons.